Physical Activity Intervention to Reduce CV Risk

Project Summary/Abstract
Background: Cardiovascular disease (CVD) remains the number one cause of death in the U.S. Physical
inactivity is a modifiable CVD risk factor, but the majority of adults are not assessed and receive no counseling
on engaging in physical activity (PA) by their healthcare provider (HCP). This leaves physical inactivity as the
only major CVD risk factor not routinely addressed. Promotion of PA by HCPs is endorsed by the American
Heart Association. Therefore, the purpose of this feasibility study is to implement the standardized assessment
promotion and monitoring of PA in the clinic setting. Specifically, the two aims of this study are to: test the
preliminary clinical efficacy of a PA promotion intervention on patients' cardiovascular risk profile (PA,
cardiorespiratory fitness, BMI, waist circumference, blood pressure, lipids, and Framingham Heart Study Risk
Score); and to evaluate the implementation of the PA promotion intervention. Methods: Participants will be
adult patients (>18 years) being seen in a preventive cardiology clinic. PA will be assessed using the 3-
question validated Physical Activity Vital Sign: “1) “On average, how many days per week do you engage in PA
or exercise?”; 2) “On average, how many total minutes of PA or exercise do you perform on those days?”; and
3) “Describe the intensity of your PA or exercise (light=casual walk, moderate=brisk walk, or
vigorous=jogging)”. An automated decision support will alert the HCPs to patients achieving less than 50% of
current recommended levels of PA, and generate an automated PA recommendation. Recommendation
options will include a referral for cardiac rehabilitation for eligible patients, or recommendations to increase
duration and/or intensity of PA. Patients will receive a written summary of their PA vital sign with
recommendations. Participants in the study will receive an activity tracker to monitor their PA for three months
which will be electronically integrated into their electronic health record for ongoing monitoring. Data analysis
will include assessing the preliminary efficacy of the intervention on CVD risk factors (comparing baseline to
follow-up) and performing a detailed process evaluation of the implementation based on the RE-AIM
framework (assessing the intervention's reach, efficacy, adoption, implementation, and maintenance). Findings
from this study may be used to establish routine assessment, promotion and monitoring of PA using existing
technology. The study significance is its potential to standardize “assess, promote, and monitor PA” in diverse
clinical settings. Future implications are widespread use of this standard protocol, which may positively impact
this prevalent risk factor for CVD. Career Development Plans: The long-term goal of the training plan is to
prepare the candidate for a research career based in informatics, implementation science, clinical trials, and
behavior change interventions aimed at reducing CVD risk through improved levels of PA. The immediate
goals of this training plan are to provide the candidate with hands-on experiential learning in developing,
implementing and assessing a technology-based PA decision support tool.

Public health relevance
Public Health Relevance Statement (Project Narrative) Cardiovascular disease is the leading cause of death in the U.S., with many risk factors, including physical inactivity. Assessment and promotion of physical activity in the clinical setting is endorsed by the American Heart Association, but is not routinely done. This implementation study will develop and test a physical activity promotion intervention embedded in the electronic health record that will standardize the assessment, promotion, and monitoring of physical activity, which may lead to widespread dissemination and improved outcomes for patients at risk for cardiovascular disease.